Intraoperative OCT Guidance of Intraocular Surgery

PROJECT SUMMARY
This is a resubmission application for a Bioengineering Research Partnership (BRP) which brings together
a highly collaborative and experienced team of engineers and ophthalmic surgeons to advance the state of the
art in image-guided surgical interventions. We seek to overcome limitations to the surgeon’s current stereo
microscopic view of ocular structures by continuing to integrate optical coherence tomography (OCT) technology,
which is already well accepted in ophthalmic practice, into the operating room. In modern ophthalmic
microsurgery, the limited depth perception and capacity for data within oculars, the physically demanding
constraints the microscope places on the surgeon, and the inability to distinguish delicate, microscopic tissue
structures of subtle contrast limits achievement of surgical endpoints and patient outcomes.
Over the past seven years, our team has developed the leading intra-operative OCT program in ophthalmic
surgery in the US. Under initial R21 support, our first-generation microscope-integrated OCT (MIOCT) design
enabled live cross-sectional imaging during surgery, and is the approach which has been adopted by multiple
vendors in current commercial offerings. Our current BRP funded work introduced the first live “4D” (volumetric
imaging through time) MIOCT technology which images microsurgery with micrometer-scale resolution at several
fully rendered volumes per second, interactively viewable by the surgeon from an arbitrary perspective through
a novel stereoscopic heads-up display. We have demonstrated and documented the performance of these
systems in over 250 live human eye surgeries at the Duke Eye Center, with innovations and results documented
in over 95 publications and presentations resulting from the prior BRP funding period by Partners and other team
members.
The overall goals of the proposed renewal project are to instigate dramatic technical advances to continue
surgeon-driven improvement of live 4D MIOCT surgery, and to enhance the utility of OCT image-guided
microsurgery by improving related aspects of the surgical milieu. To do this, we will significantly increase the
speed and ease of use of intra-operative MIOCT by developing next-generation OCT engine technology coupled
with a novel wide-field automated eye-tracking MIOCT scanner. We will empower surgeons to take full
advantage of this new information by developing novel integrated data visualizations including operating room
high-definition 3DTV and augmented/virtual reality head-mounted displays. Each of these improvements are
motivated by specific current needs in both macular and anterior segment surgery, and will be developed through
our well-established translational methodology of incorporating iterative feedback between multidisciplinary team
members. We believe this developments will not only improve outcomes in current surgeries, but will also enable
novel ophthalmic and other microsurgeries not possible due to current limitations in surgical practice.

Public health relevance
PROJECT NARRATIVE This Bioengineering Research Partnership renewal proposal brings together a multidisciplinary team of experts in ophthalmic imaging and surgery to advance the state of the art in image-guided ophthalmic surgery. The overall five-year goals of the project are to develop novel technology to provide actionable new information through provision of live volumetric imaging during surgery, improving surgical practice and outcomes. We believe this technology will enable novel ophthalmic and other microsurgeries not possible due to current limitations in surgical visualization.